CELLULAR AND MOLECULAR CONTROLS OF BIOMINERALIZATION

The overall objective of this Program Project is to provide new and fundamental information on how nature controls mineralization in developing mineralized tissues, like enamel, using amelogenesis as a model. Our overall working hypothesis is that the formation of the highly organized enamel tissue results from genetically-controlled processes involving: cell motility, mineral ion fluxes; the secretion, self assembly and processing of matrix proteins, and the subsequent control of nucleation and crystal growth by specialized proteins coupled with the cell-controlled establishment of inherent driving forces to support mineralization. Specifically, we propose to elucidate fundamental mechanisms which control enamel formation through integrated studies on: 1). matrix protein-mineral interactions in the control of crystal nucleation and crystal growth; 2) the cellular (ameloblast) control of mineral ion transport, extracellular mineral ion composition, pH. and the driving force for mineral deposition; 3) the role of specific protein-protein interactions in the control of mineralization; 4) the control of protein function and mineralization via the processing of enamel-matrix proteins by tissue-specific proteinases; and 5) cell (ameloblast)-cell interactions and cell-matrix interactions, leading to the control of cell motility and enamel patterning. These studies will be carried out through the integration of five independent projects facilitated by a Protein Core, which will generate recombinant enamel proteins in both bacteria and eukaryotic cell expression systems. These areas of research will be addressed in a multi-disciplinary fashion using state-of-the-art techniques (e.g. the yeast two-hybrid system; PCR-based homology cloning, atomic force microscopy, confocal microscopy and direct 3-D fluorescence microscopy; SEM and TEM; immunohistochemistry) and physiochemical considerations to address the overall mechanisms of enamel formation. Long term, this information will be useful in: 1) the design of new methodologies for the preparation of biomaterials with specific desirable properties; 2) the diagnosis and prevention of diseases mineralized tissues through genetic means; and 3) the design of procedures for the regeneration of damaged and diseases mineralized tissues.